The Role of Tbet+ B cells in viral reinfection

Abstract
B cells differentiate to produce antibodies that neutralize and inhibit viral entry aiding in host protection from
infections. Following infection, B cells undergo CD4 T cell-dependent maturation and differentiation either in
germinal center (GCs) or extrafollicular (EF) pathways within secondary lymphoid organs. B cells that have the
potential to differentiate into antibody-secreting cells (ASCs) following secondary infections such as
conventional memory B cells and CD11c+Tbet+ B cells are generated via both EF and GC reactions. Yet, the
specific contribution of each of these B cell subsets to the generation and activity of anti-viral antibodies upon
re-infection remains unclear. CD11c+Tbet+ B cells (herein referred to as Tbet+ B cells) are a distinct B cell
subset that differentiate following viral infections as well as autoimmunity in mice and humans. Emerging
studies have shown that in murine and human infections, Tbet+ B cells are critical drivers of protective
antibodies. Tbet+ B cells are capable of differentiating into class-switched autoantibody-secreting cells upon
stimulation by cytokines and TLR agonists. Additionally, these B cells have elevated expression of MHCII and
secrete inflammatory cytokines such as IFNg and IL-12 following stimulation, suggesting a role in effector T cell
activation. The development of Tbet+ B cells in a primary infection has been well elucidated, but their
differentiation and contribution to host protection following secondary viral infection is poorly understood. Our
new data and published studies demonstrate that Tbet+ B cells develop from the GC response, but mainly
arise from the EF pathway following a primary viral infection. However, whether Tbet+ B cells that arise from
GC or EF origin have different functions upon re-infection is unknown. Currently, we found that following the
resolution of a viral infection both the GC and EF-derived Tbet+ B cells persist in the spleen. However, upon re-
infection, the GC population appears to form secondary GCs or differentiate into ASCs, while the EF maintains
a Tbet+ B cell phenotype indicating a role for T cell-mediated immunity. We hypothesize that the developmental
origin of Tbet+ B cells influence their differentiation and function following secondary viral infection.
Accordingly, our study will dissect how GC and EF origin impact transcriptional regulation and localization of
Tbet+ B cells. We will utilize an allotypic transfer system to discern the protective contributions of Tbet+ B cells
versus memory B cells following re-infection. We expect this work to reveal a novel mechanism of Tbet+ B cell
regulation that critically impacts the host response following infection. Ultimately, this work should provide
insight into new therapeutic targets to boost antibody responses and/or effector CD4 T cell responses in
immunization strategies or during secondary infection or dampen harmful humoral responses during
autoimmunity.

Public health relevance
NARRATIVE Understanding how different memory B cells populations function following reinfection with differnet viruses. This study explores the regulation of these cells by their cellular interactions in viral infections and may provide new targets for future therapeutics.